UCSF-UCB TRAC Clinical Sciences Core

PROJECT SUMMARY – Clinical Science Core
Progress towards meeting global public health tuberculosis (TB) targets for reductions in incidence, mortality
and catastrophic costs have been slow, and appear to have stagnated due the recent COVID-19
pandemic. Without reinvigorating TB clinical research with an infusion of new investigators, novel perspectives,
and cutting-edge innovation, we remain at risk of allowing the TB pandemic to continue unabated. The goal of
the Clinical Science Core of the UCSF-UCB TRAC is to augment existing UCSF and UCB resources to
accelerate clinical research by engaging New Investigators and established investigators new-to-TB, and by
reducing the barrier to conducting high-quality, innovating clinical research. UCSF-UCB TRAC Clinical Science
Core will support investigators by 1) providing consultation on key aspects of TB clinical research; 2) providing
consultation about novel methodologic approaches in clinical research that may be applied to TB; 3) facilitating
access to clinical cohorts, datasets, bio-specimens, and clinical research tools; 4) supporting meaningful
community engagement via a TRAC TB Community Advisory Board; 5) supporting career development of new
investigators with targeted mentorship. The Clinical Science Core will encourage an interdisciplinary approach
to TB clinical research by making services and resources available for researchers from diverse fields including
basic sciences, epidemiology, bioinformatics, public health, social sciences and clinical sciences. The Clinical
Science Core hopes to attract and inspire a new generation of TB scientists to accelerate TB biomedical and
clinical research with the support of UCSF-UCB TRAC faculty who are leaders in TB clinical sciences.